Comparison of Exercise Mode on Disruptions in Calcium Homeostasis

Endurance exercise is frequently recommended as a means to reduce the risk of cardiometabolic diseases
and to reduce the risk of osteoporotic fracture. However, bone does not always adapt in the way that would be
expected, and there is evidence that endurance exercise may lead to bone loss under certain conditions. It is
our contention that disruptions in calcium homeostasis during exercise, resulting in decreases in serum ionized
calcium (iCa) and increases in parathyroid hormone (PTH) and c-telopeptide of type I collagen (CTX; a marker
of bone resorption) at the onset of exercise, may be responsible for the lack of improvements in bone mineral
density that are anticipated. Acute studies in this area have predominantly focused on young, healthy adults,
primarily men, during stationary cycling exercise. Few studies have been conducted in older adults, but those
studies have found that older adults experience similar disruptions in calcium homeostasis in response to an
acute bout of endurance exercise. Preliminary comparisons of our studies, as well as research from other labs,
also suggests that that mode of exercise conducted during these acute exercise bouts may be an important
determining factor in the catabolic bone response to exercise. It appears that weight-bearing exercise (i.e.,
treadmill) results in smaller increases in PTH and CTX compared to weight-supported exercise (i.e., stationary
cycling). This has never been tested using a within-subjects design, so it is unclear if these observed
differences are due to the mode of exercise, lab-to-lab differences, or other underlying factors. To address this
gap in knowledge, 30 Veterans (15 men, 15 women), aged 60+ years, will complete two 1-hour acute exercise
bouts: 1) brisk treadmill walking at 70-80% of maximal heart rate; 2) vigorous stationary cycling at 70-80%
maximal heart rate. Blood samples will be collected to measure iCa, PTH, CTX and procollagen type I n-
terminal propeptide (P1NP) before, during, and after each exercise bout. The order of the exercise bouts will
be randomized and counter-balanced. The primary aim is to determine if mode of exercise results in a
differential bone biomarker response in older Veterans. This information is essential for understanding how
future exercise interventions should be designed to benefit both cardiometabolic health and bone health. This
is especially relevant to Veteran health due to the high burden of both cardiometabolic diseases (e.g.,
diabetes, heart disease) in the population, as well as evidence of increased osteoporotic fracture risk. The
proposed research is significant because it is addressing a knowledge gap that has prevented the ability to
design exercise and lifestyle interventions aimed at preserving multiple components of Veteran health, which
could have a lasting impact on Veteran quality of life and functional independence. The proposed research is
innovative because it is testing a novel hypothesis, the mode of exercise on disruptions in calcium
homeostasis, in a population that could greatly benefit from the knowledge to be gained. While the proposed
research is an acute study, the results generated will be used to design future clinical interventions for Veteran
health. Long-term, information gained from this research will help to define the optimal exercise prescription to
improve cardiometabolic without compromising bone health aging Veterans.

Public health relevance
Endurance exercise is often recommended to improve cardiometabolic health and maintain bone health throughout life and to prevent osteoporotic fracture. However, there is evidence to suggest that bone does not always adapt in the way that is expected, and that endurance exercise may lead to bone loss under certain conditions. Disruptions in calcium homeostasis during exercise may explain this observation, and preliminary data suggests that the mode of exercise (i.e., cycling versus treadmill) may result in different magnitudes of change in bone biomarkers. The purpose of this study is to determine if mode of exercise results in a differential bone biomarker response to an acute exercise bout in older Veterans. Blood samples will be collected before, during, and after 2 acute exercise bouts: 1) brisk treadmill walking; and 2) vigorous stationary cycling. Bouts will be matched for relative intensity and duration. This data will be used to develop future exercise interventions in older Veterans aimed at preserving both cardiometabolic and bone health.